Cryptococcal vaccine development based on strong immunity induced by morphological strains

Abstract
Cryptococcal meningoencephalitis (CME) is responsible for more than 15% of the total deaths of AIDS
patients. The disease claims hundreds of thousands of lives each year, with global mortality rates of ~70%
despite antifungal therapies. Unfortunately, there is no vaccine clinically available for cryptococcosis. The
challenges of preventing and treating this fungal disease motivate our investigation of cryptococcal pathways
that can induce a strong protective host response. The encapsulated fungus Cryptococcus neoformans is
known to undergo yeast-to-filament morphological transition. We previously showed that morphotype of this
fungus has a profound effect on its interaction with various hosts. In mammalian models of cryptococcosis, the
yeast form is pathogenic while the filamentous form is not. We established that the transcription factor Znf2,
which drives filamentous growth, is a powerful anti-virulence regulator. Cryptococcal cells overexpressing
ZNF2 (ZNF2oe) are avirulent and elicit strong and long-lasting protective immunity, which serves as an effective
vaccine against subsequent lethal challenges. Importantly, we showed that once mice are vaccinated with
ZNF2oe cells, their CD4+ T cells are dispensable for protection at the time of fungal challenge (mimic
people with HIV prior to AIDS). Furthermore, vaccination with ZNF2oe cells even in hosts with pre-
existing CD4+ T cell deficiency is also protective against cryptococcosis (mimic AIDS patients). These
findings are important because the majority of cryptococcosis patients are AIDS patients with low CD4+ T cell
counts, and our preclinical studies suggest that cryptococcal vaccines could be effective in these individuals.
The long-term goal of this project is to characterize the filamentation pathway and explore it for
therapeutics (e.g. vaccines). We have made significant progress in establishing the link between morphotype,
virulence and immunity, and discovered multiple regulators required for both Znf2-directed filamentation and
Znf2-induced host immunity. Recently, we also identified mutations that block Znf2's function in filamentation,
but do not affect its ability to induce host protective effects. These findings provide a unique opportunity to
pinpoint cryptococcal factors associated with host protective effect of Znf2. Because ZNF2oe in both heat-
inactivated and live cells provides host protection, we predicted that extracellular components of ZNF2oe cells
are important protective immunogens. Consistently, host protection elicited by ZNF2oe cells depends on the
capsule where extracellular antigens are localized. Additionally, our preliminary data revealed that some
antigens are secretory proteins including several glycosylphosphatidylinositol (GPI)-anchored glycoproteins.
Capitalizing on these discoveries and our expertise in mRNA lipid nanoparticle (mRNA-LNP) technology, we
aim to (1) define cryptococcal factors that are important for Znf2's anti-virulence effect; (2) identify
immunogens that elicit protective host responses; and (3) use selected immunogens to develop
mRNA-LNP or recombinant protein vaccines against cryptococcosis.

Public health relevance
The relevance of this research to public health: Cryptococcal meningoencephalitis poses a serious threat to public health, causing hundreds of thousands of deaths each year. Cryptococcus neoformans is a fungal pathogen of the top critical priority listed by WHO. There is no clinically available vaccine against Cryptococcus neoformans, and the long-term goal of this project is to identify cryptococcal factors that can induce protective host responses and use these immunogens to develop mRNA-LNP vaccines or recombinant protein vaccines against cryptococcosis.